Transcription: Mechanism and Regulation

PROJECT SUMMARY/ABSTRACT
The work proposed is designed to understand how gene expression control at the transcriptional level
results from alterations in the activity of RNA polymerase (RNAP). Escherichia coli RNAP serves as an
exceptional model system for mechanistic studies of transcription and as a paradigm for understanding gene
expression in bacteria. Bacteria live in complex, fluctuating environments requiring gene expression to be
highly responsive to changes in growth state or environmental conditions. The expression of a given gene is
determined by contributions from the sequence of the DNA template, regulatory proteins, and reaction
conditions. While the input provided by DNA sequence is “hard-coded” (barring mutational change), the inputs
provided by regulatory factors and reaction conditions are flexible, enabling them to change in response to
alterations in environmental conditions. A multitude of transcription factors and reaction conditions can
modulate gene expression. Thus, changes in gene expression occurring in response to alterations in growth
state or environmental conditions cannot be predicted a priori from DNA sequence alone. Experiments
proposed will enable a systems-level description of the sequence-dependent, factor-dependent, condition-
dependent transcriptional landscape in Escherichia coli. Each step of transcription can be rate limiting, and
thus serve as a potential target of regulation. During the project period, mechanisms of transcriptional control
during initial transcription and elongation, i.e., the stages when RNA synthesis occurs, will be investigated. In
future work, studies will expand to include initiation and termination, using similar approaches. A distinguishing
feature of the work described has been the development of methods to monitor transcription across extensive
sequence space, both in vitro and in vivo. In addition, the flexibility provided by use of E. coli RNAP as a model
system, enables straightforward analysis of the contributions of any transcription factor or reaction condition to
RNAP activity, both in vitro and in vivo. The results of empirical measurements of RNAP activity across
extensive sequence space or across the entire E. coli genome will be integrated into a site- and base-specific
quantitative model describing how RNAP activity is specified by inputs from DNA sequence, transcription
factors, and conditions. The biological knowledge gained will provide an unprecedently rich description of the
architecture of gene expression control in E. coli and provide the basis for extending this approach to other
organisms, including eukaryotes.

Public health relevance
PROJECT NARRATIVE Proper control of gene expression is critical for organismal development, cellular response to environmental signals or stress, and the prevention of disease states. The proposed work seeks to identify fundamental mechanistic principles that underpin the control of gene expression at the level of RNA synthesis. Thus, these studies will provide key insights into the cellular mechanisms that govern development, enable cells to respond to environmental signals or stress, and that prevent the emergence of disease.